Sonic Hedgehog Signaling in Neocortical Growth and Folding

Project Summary
The neocortex, a structure covering mammalian brains, computes high-order sensory, motor, and cognitive
processes. Over the course of evolution, the neocortex of certain species expanded dramatically and folded,
thereby conferring superior sensorimotor and cognitive abilities. The immense expansion of the neocortex in
humans made possible the complex behavior, cognition, and intellect unique to our species. Neocortical
expansion and folding reflect an increase in the number of neural cells and, therefore, depend on the number of
neural progenitors (NPs). The long-term goal of this project is to understand the mechanisms regulating NP
expansion and neocortical growth and folding. Sonic hedgehog (SHH) signaling promotes NP expansion. In
mice, ectopically elevated SHH signaling activity causes the neocortex to expand and fold. SHH signaling also
increases the number of NPs in the ferret, a species with a naturally folded neocortex, and in human cerebral
organoids, miniature models of the developing brain grown from human pluripotent stem cells. SHH signaling
expands NPs by regulating transcription. The short-term goal of this project is to understand how transcriptional
programs downstream of SHH signaling expand NPs. Preliminary data show that cyclin-dependent kinase 6
(CDK6) regulates a transcriptional program that drives NP expansion downstream of SHH signaling and that a
histone H3 mutation (H3pG34R) that is recurrent in pediatric brain cancer disrupts the SHH signaling–driven
transcriptional program driving NP expansion. Mutations in CDK6 and histone H3 are associated with
neurodevelopmental disorders and brain tumors. Based on these findings, this project will investigate
transcriptional programs driving NP expansion and mechanisms regulating the transcriptional programs by using
mouse models and human NP models that have gain- or loss-of-function mutations in SHH signaling, CDK6,
and histone H3. This project has two main aims. Aim 1 is to investigate how CDK6 regulates transcriptional
programs downstream of SHH signaling to expand NPs. For this aim, we will investigate (1.1) how SHH signaling
and CDK6 affect the transcriptome of each NP type in situ by employing a novel spatial transcriptomic method
with subcellular resolution and high transcriptome output and (1.2) how SHH signaling and CDK6 affect histone
modifications and chromatin structure to regulate transcription. Aim 2 is to investigate how the H3pG34R mutation
affects NPs. For this aim, we will investigate (2.1 and 2.3) the effects of the H3pG34R mutation on the behavior
and transcriptional program of NPs and (2.2) how mutations that co-occur with H3pG34R in pediatric brain cancer
modulate the effects of H3pG34R on NPs. The proposed study will provide important insights into the transcriptional
regulation of NP expansion and how CDK6 and H3 mutations affect such transcriptional programs, thereby
deepening our mechanistic understanding of brain development, evolution, and diseases.

Public health relevance
Project Narrative The unique mental abilities of humans are rooted in the immensely expanded and folded neocortex, which reflects the expansion of neural progenitor/stem cells. Abnormal size or folding of the human neocortex can cause intellectual disability and other neurological disorders. By defining the mechanisms regulating neural progenitor/stem cell expansion, the proposed research will help us to understand the mechanisms underlying such disorders that are caused by genetic and other factors, including controlled substances and certain viruses.